THE PURPOSE OF THIS CONTRACT IS TO ESTABLISH COLLECTION SITES(S) (I.E., THE NIH BRAIN AND TISSUE REPOSITORY (NBTR)) TO PROVIDE SERVICES THAT WILL ACTIVELY ACQUIRE, RECEIVE, PROCESS, STORE, CURATE, PRE

"This contract is for post-mortem human brain collection sites (i.e. the NIH Brain and Tissue Repositories [NBTR]) for the NIH NeuroBioBank. This contract is part of a strategy by the NIH to maximize availability of post-mortem human biospecimens to the research community while simultaneously achieving greater efficiency and better coordination of brain and tissue repository resources through a centralized approach to brain banking."